Postnatal transient connectivity in brain development and implications in fragile x syndrome

ABSTRACT
Fragile X syndrome (FXS) is the most common genetic cause of autism spectrum disorders. Autism
symptoms in FXS patients typically manifest during early infancy when children actively interact with their
environment and form sensory-cognitive associations. During this stage, the neocortex undergoes extensive
experience-dependent synaptogenesis and synaptic pruning to either maintain or eliminate, so-called transient,
neuronal circuits. Several studies suggest that both sensory and neuromodulatory inputs to the cortex can
establish transient connections with specific cell-types, and subsequently contribute to the maturation of proper
adult cortical circuits. Given that early behavioral therapy is widely considered to be the most effective treatment
for children with autism, pharmacological manipulations of sensory and neuromodulatory transient connectivity
at the early onset of the disorders could potentially mimic or synergize with the effects of such beneficial
behavioral therapies. However, to date, the role and mechanisms of transient connectivity in normal and FXS-
associated cortical maturation remain largely unknown.
To address this knowledge gap, we propose to investigate the mechanisms of transient connectivity
underlying sensory- and neuromodulatory-dependent cortical maturation in control mice and in a mouse model
of FXS. Sensory experiences are encoded in the cortex by thalamocortical (TC) neurons forming transient
connections with a subset of inhibitory neurons, the somatostatin (SST) cells. These transient connections are
believed to control maturation of excitation/inhibition (E/I) balance in the cortex, which is altered in the mature
brain of FXS mice or patients. Our mouse data indicate that, in parallel to sensory TC inputs, SST neurons
receive cholinergic modulatory inputs associated with the early development of TC pathways. Therefore, we
hypothesize that the synergy between TC and cholinergic transient connectivity to SST neurons is an instructive
mechanism that triggers cortical maturation and that this mechanism is impaired in FXS. Our previous research
using combinatorial mouse genetics and viral chemogenetic approaches showed that metabotropic signaling
controls the formation of transient TC inputs to SST neurons. Based on this data, we propose that cortical E/I
maturation results from metabotropic signaling that transiently transduces sensory cues and neuromodulation
onto SST neurons. To test this hypothesis, we will employ multidisciplinary approaches to investigate whether
transient TC connectivity governs healthy and FXS cortical maturation (Aim 1), elucidate the role of cholinergic
inputs in the maturation of healthy and FXS cortical circuits (Aim 2), and characterize metabotropic molecular
pathways underlying transient connectivity (Aim 3).
Overall, our work will provide novel insights into the role of transient connectivity on sensory and cognitive
experience-dependent cortical maturation and lay the foundations for exploring approaches targeting the onset
of circuit dysfunctions in FXS.

Public health relevance
PROJECT NARRATIVE Fragile X syndrome is the most common genetic cause of autism and symptoms of autism typically emerge during early infancy, a time when the neocortex undergoes extensive synaptogenesis and synapse elimination, so-called transient connectivity. Using multi-facetted approaches, including electrophysiology, single-cell transcriptomics and CRISPR strategy, we will investigate the role of sensory and neuromodulatory transient connections in the development of healthy and FXS cortical maturation. This work will provide novel insights into the role of transient connectivity on sensory and cognitive experience-dependent cortical maturation and lay the foundations for exploring approaches targeting the onset of circuit dysfunctions in FXS.